Cerebellar-Cortical Circuitry and Treatment Response in Early Psychosis

Abstract
Identifying circuitry-based biomarkers of treatment response to antipsychotic medication is critically important
for precision psychiatry, which may help physicians make optimal treatment plans at the early stage, reducing
the course of ineffective treatment and benefiting long-term life quality of patients. Using functional magnetic
resonance imaging (fMRI) and two clinical samples of first-episode psychotic patients (n = 49 and 24,
respectively), our recent work has identified that connectivity in the cerebellar-cortical circuitry is a state-
independent predictor of antipsychotic response that shows the best predictive value across the whole brain,
regardless of fMRI paradigm. This finding strongly points to a promising prognostic biomarker with potential to
be clinically translated for assessment of treatment efficacy. The goal of the proposed study is therefore to
collect new patient data to validate this identified predictive biomarker in a larger sample (120 patients with
first-episode psychosis, Aim 1). Given the state-independent nature of the identified predictive biomarker, we
will use naturalistic stimuli instead of traditional high-demand cognitive tasks as fMRI paradigms, which are
more patient-friendly and thus may facilitate the application of this biomarker in a real clinical scenario. Using
this new dataset, we will further refine functional predictors in the cerebellar-cortical circuitry based on
connectivity of each cerebellar system (Aim 2), and develop white matter structural predictors related to the
superior cerebellar peduncle (the major efferent fiber of the cerebellum sending information to the cerebral
cortex) and middle cerebellar peduncle (the major afferent fiber of the cerebellum receiving information from
the cerebral cortex, Aim 3). The results derived from multimodal imaging data will further be used to train an
updated prediction model based on both regularized regression and deep learning, with the model
performance to be externally validated in our in-house dataset (Aim 4). This will eventually establish an
optimized, validated, and generalizable cerebellum-based predictive model for future clinical use.

Public health relevance
Project Narrative Psychotic disorders are severe mental disorders with treatment response highly variable among patients, making the investigation of predictors of treatment response critically important. We have recently identified that connectivity in the cerebellar-cortical circuitry is a promising prognostic biomarker with the best predictive value across the whole brain. This study aims to further validate this biomarker and to develop predictors in the cerebellar-cortical circuitry for future clinical use.